Campaigns and Underserved PopulationsPeriod of Performance: September 22, 2015 - September 21, 2016

National Cancer Institute (NCI) has developed smoking cessation services for multiple population groups and diverse audiences. NCI needs to provide core support for the content and on-line resources to effectively reach these populations and audiences. the Contractor shall design, develop, and monitor the performance of outreach campaigns promoting the Smokefree.gov program, including its web sites, text message programs, social media resources, and mobile applications. The focus is on cancer survivors and Spanish speaking populations.